ILOPROST IN PATIENTS WITH SEVERE ATHEROSCLEROTIC PERIPHERAL ARTERY DISEASE

To evaluate the effects of a prostacyclin drug Illoprost on the healing of lower extremith ischemic ulcerations using a randomized sample approach.